Resilient Families (R-FAM): A dyadic resiliency intervention for parents of babies in neonatal intensive care

PROJECT SUMMARY
This K23 proposal details a 5-year training program that will help launch my career as an independent clinical investigator
who develops, tests, adapts, and implements resiliency interventions for families managing stressful reproductive life events.
I propose an innovative and clinically meaningful research and training plan consistent with my career development goals.
Background: With 400,000 U.S. newborns admitted to Neonatal Intensive Care Units (NICU) annually, up to 50% of their
parents experience emotional distress (depression, anxiety, posttraumatic stress) during and after hospitalization. Emotional
distress can negatively impact couple and family adjustment, and in turn, child health and development. Building resiliency
in parents early during the NICU journey is key to improve family and child outcomes. Specific aims and research design:
My goal is to develop, refine, and test the feasibility and acceptability of an innovative, resiliency intervention (“Resilient
Families;” R-FAM) for parental dyads (couples) with babies in the NICU. To achieve this goal, my aims are three-fold: (1)
develop R-FAM using stakeholder input from interviews with parent dyads (N=20) and focus groups with NICU staff (N=4);
(2) optimize R-FAM through an open pilot (N=5 dyads) with pre/post assessments and exit interviews; and (3) test R-FAM
for feasibility and acceptability (N=50 dyads) through a pilot randomized clinical trial of R-FAM compared with a minimally
enhanced usual control (MEUC). Findings will inform a subsequent R01 hybrid efficacy-effectiveness trial (R-FAM versus
MEUC) and future R01 mechanistic, adaptation, and implementation trials. Training and mentoring: My research aims
are supported by three training goals: (1) qualitative methods, including longitudinal, dyadic interviews and focus groups;
(2) intervention design and optimization using mixed methods; and (3) conduct dyadic randomized clinical trials. My
research and training goals are supported by: (1) expert mentors (Vranceanu & Lerou) and advisors (Patterson, Kaimal, &
Parker); (2) a rich and supportive institutional environment; and (3) targeted coursework, scientific meetings, trainings, and
planned publications. Relevance to NICHD. This K23 directly aligns with NICHD’s funding priorities to improve treatment
and wellness of women and families who experience high-risk pregnancy-related morbidities (Strategic Plan 3). Impact:
This K23 award will provide me with the research experience, collaborations, mentorship, and training I need to become an
independent and successful clinical investigator in perinatal-neonatal health. I hope to develop, adapt, test, and implement
resiliency interventions that aim to improve emotional distress and relationships in families during the perinatal-neonatal
period. If successful, this work can help inform future adaptations of R-FAM (R01s) that meet the unique needs of different
families, such as single parents, parents coping with loss, non-romantic dyads, and families from diverse cultural
backgrounds. R-FAM has the potential to set a new standard of NICU psychosocial care—therefore improving the outcomes
and culture of these healthcare units across the globe.

Public health relevance
PROJECT NARRATIVE The proposed study will establish the feasibility and acceptability of a novel tailored, dyadic, resiliency intervention, “Resilient Families (R-FAM).” R-FAM aims to improve emotional distress and couple functioning in parents with babies in Neonatal Intensive Care Units (NICU)—who are at increased risk (30-50%) for acute and chronic distress. R-FAM has the potential to enhance family adjustment, child development, and ultimately inform a new and improved standard of care in NICUs across the world.